Investigating the impact of heterogeneous and homogenous neoantigen expression patterns on the anti-tumor immune response

PROJECT SUMMARY/ABSTRACT
Immunotherapies like checkpoint blockade therapy (CBT) have been a breakthrough for cancer treatment with
durable responses observed in patients with advanced disease. However the majority of patients do not respond
and factors leading to resistance remain largely unknown. While clinical data have shown that neoantigen load
positively correlates with overall survival and response to CBT, there are patients with apparent neoantigens
who show partial or no response. Emerging evidence suggests that the context of neoantigen expression can
impact the immune response, where tumors with clonal neoantigens expressed by all tumor cells elicit robust
anti-tumor immunity and correlate with CBT response while tumors exhibiting a high degree of intratumoral
heterogeneity (ITH), where unique neoantigens are expressed by subclones, display weaker responses. How
neoantigen expression patterns can elicit such dissimilar responses is not known. To elucidate how
heterogeneously expressed neoantigens can dampen the immune response we created a novel murine tumor
model to implant tumors where the same set of neoantigens are expressed homogeneously or heterogeneously.
Using this system we have observed that tumors with high ITH are weakly immunogenic compared to
homogenous tumors. Intriguingly, our preliminary data also suggest that an earlier and more robust T-cell
response against a weakly immunogenic neoantigen can be induced if it is expressed with a very immunogenic
neoantigen. This response leads to even more efficient tumor control than that observed in the cell line
expressing only the strong neoantigen. These preliminary data led us to hypothesize that weaker anti-tumor T-
cells responses against heterogeneously expressed neoantigens are mediated by a reduction in dendritic cell-
mediated T cell priming. To address this question I propose to:
1. Determine the impact of heterogeneous neoantigen expression on anti-tumor T-cell responses.
2. Determine the mechanistic basis for weaker anti-tumor immune response in heterogeneous tumors.
By addressing these aims we will gain critical insight into fundamental factors necessary for a productive anti-
tumor immune response which would have significant impact on immunotherapeutic design, particularly for
treatment of patients with high ITH.
Work on this project will foster my development as an independent scientist as I gain additional
experience performing hypothesis-driven science at the Koch Institute at MIT. I will interact with, receive
feedback from and collaborate with current and future leaders in cancer biology research here. Furthermore, this
environment stresses integration of basic cancer research and bioengineering to drive treatment discovery which
will provide me with opportunities to learn how I can translate my discoveries, especially as I further develop my
collaborations. Ultimately, this project will train me in the overall approach to asking and addressing fundamental
questions in cancer biology.

Public health relevance
PROJECT NARRATIVE There is mounting evidence that hetereogeneous expression of neoantigens in a tumor could be a mechanism of resistance to immunotherapy, yet this is no understanding of how this is achieved molecularly. Using a novel murine tumor model we aim to elucidate the mechanistic basis for weakened immune responses to hetereogeneously expressed neoantigens. Our discoveries will provide insight into additional fundamental factors for productive anti-tumor immune responses and stand to inform future design of immunotherapies, in particular neoantigen vaccines, to increase the number of patients who can benefit.